95GHZ SPECTROMETER DATA ANALYSIS CO-COMPUTER

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. Primary support for the subproject and the subproject's principal investigator may have been provided by other sources, including other NIH sources. The Total Cost listed for the subproject likely represents the estimated amount of Center infrastructure utilized by the subproject, not direct funding provided by the NCRR grant to the subproject or subproject staff. We have acquired and installed a second, subsidiary data processing computer (Red Barn/dual core custom configuration) as a solution to the bottleneck of otherwise using the system control computer for data analysis and plotting. This computing upgrade path was chosen instead of the significantly costlier alternative of replacing the existing 95GHz spectrometer system control computer, an upgrade that would have required building a custom chassis at relatively much greater expense. More importantly, performance analysis of the single-computer solution indicated that high priority real-time control of the spectrometer operations would often conflict with computationally intensive processing required for post-collection data analysis. Addition of the second computer has eliminated the potential for such conflicts. Additional Python scripting has been incorporated into the spectrometer control computer to automate transfer of data files to the data analysis/plotting system during the course of experiment collections. Subsequent data analysis and plotting is primarily conducted in a MatLab environment and is effectively off-line with respect to system computer control of ongoing experiments.